1) EXERCISE ADDITIONAL "UP-TO HOURS" DURING OPTION YEAR TWO (2)2) REVISE ATTACHMENT 2: OTHER TERMS AND CONDITIONS, P.4, HHSAR 352.237-75 KEY PERSONNEL TO SUPPORT THE NIMH NDA WHICH IS A SINGLE DATA

The NIMH Data Archive is a fully operational system that supports data ingestion, management, access, and compliance across a diverse array of user communities and data types. As NDA scales to accommodate more users, to support an increasing data volume, and to deal with new types of data containing personally identifiable information, the program must transition from its current state to a fully-hardened enterprise information system that securely supports deidentified and sensitive data from thousands of NIH-funded research projects and federates with other data repositories worldwide.